IVIG TREATMENT OF CHILDREN WITH SYMPTOMATIC HIV INFECTION

Intravenous gammaglobulin is being evaluated for possible beneficial effect in the treatment of secondary infections in infants and children with HIV infection and AIDS.